Flow Cytometry & Single Cell Core Facility (FCSCCF)

PROJECT SUMMARY/ABSTRACT - Flow Cytometry and Single Cell Core Facility (FCSCCF)
The mission of the WVU Flow Cytometry and Single Cell Core Facility (FCSCCF) is to provide state-of-the-art
technologies, instrumentation, and expertise for biomedical research. As part of the Tumor Microenvironment
(TME) Center of Biomedical Research Excellence (CoBRE), the WVU FCSCCF has expanded its single cell
analysis services to include single cell barcoding and library generation using a 10x Genomics Chromium
Controller and a full spectrum 3-laser Cytek Aurora analytical flow cytometer. These services/instruments
complement the other instruments in the facility including three flow cytometers (4-laser BD FACSAria III sorter,
4-laser LSRFortessa analyzer, and 1-laser Guava easycyte HT), two magnetic cell separators (Miltenyi Biotec
AutoMACs Pro and Multi-MACS24), a Fluidigm C1 Auto Prep System, a Miltenyi Biotec gentleMACS Octo
Dissociator, a Malvern Panalytical NanoSight NS300, and a ZetaSizer NanoZ. The facility has developed a
robust pipeline in collaboration with the WVU Genomics Core and WVU Bioinformatics Core to provide WVU
researchers with assistance/expertise from sample prep through data analysis. The specific aims of this
research core application are: 1) Implement and support the research projects of the TME CoBRE Project
Leaders and Pilot Project Recipients as they work toward obtaining NIH R01 funding and 2) Provide exceptional
expertise and training in the area of flow cytometry and single cell analysis to TME CoBRE-funded investigators
and other Institutional Development Award (IDeA)-funded projects at WVU. The proposal describes the services
and training provided by the facility, its management plan, fee structure, quality assurance plan, and strategies
to sustain and expand the facility over the life of the project and beyond.